Promoting follow-up of abnormal cancer screening tests using population-basedsystems to support stepped care multilevel intervention

Project Summary/ Abstract
While it is established that screening reduces cancer-specific mortality for breast, cervical, colorectal and lung
cancer, screening benefits are only realized through timely follow-up of abnormal screening results. Failure to
receive appropriate diagnostic testing undermines the benefits of screening, and violates the trust that patients
place in their providers and health systems. Cancer screening is often initiated in primary care settings but
requires complex care transitions with other providers who either perform the test or evaluate the result. Often
the transition from screening to diagnostic evaluation requires a transfer of role/ responsibility between primary
and specialist care. Incomplete follow-up of abnormal cancer screening tests represents an ongoing challenge
for primary care providers (PCPs) with barriers to follow-up at the individual (patient, provider), team, and
health system levels. We propose to develop, implement, evaluate and disseminate a health information
technology (IT)-enabled, multilevel, stepped care intervention grounded in primary care, mFOCUS (multilevel
FOllowup of Cancer Screening), to promote appropriate follow-up of abnormal breast, cervical, colorectal and
lung findings. We will develop and implement mFOCUS at 40 primary care practice sites affiliated with three
primary care networks. Key mFOCUS components include: system design to promote identification and
tracking through an electronic health record (EHR)-integrated population management platform with education
to promote culture change around the management of abnormal results; use of individual patient and PCP
reminders and tools; and a stepped-care team-level enhancement with increasing intensity of contact (i.e.,
administrative outreach, patient navigation). A 4-arm cluster randomized controlled trial (RCT) of 6,400
individuals who are due for follow-up of an abnormal screening result will allow examination of the marginal
and cumulative effectiveness of the multilevel components. Our primary outcome will be receipt of follow-up
evaluation, pre-defined by cancer type and abnormality, within 120 days of becoming due for follow-up.
Secondary outcomes will assess multi- and cross-level outcomes, such as patient-reported knowledge of their
test result and need for follow-up and satisfaction with the care provided by their PCP. Finally, we will study the
reach, adoption, implementation and maintenance of mFOCUS using patient, provider and health system
surveys and qualitative data to examine barriers and facilitators. mFOCUS builds directly upon relevant
conceptual models and the team's prior experience in comprehensive cancer screening and prevention,
primary care population management, health IT supported stepped care interventions, patient navigation, and
our proven ability to translate the results of such research into clinical practice. This type of multilevel
intervention will likely increase as payers and health systems take responsibility for population health through
new care financing and delivery models.

Public health relevance
Project Narrative Effective cancer screening requires appropriate diagnostic testing after an abnormal screening result. Timely follow-up of such abnormalities can be challenging due to the complex interactions among patients, primary care providers (PCPs) and specialists. We propose to develop, implement, evaluate and disseminate a health information technology (IT)-enabled, multilevel, stepped care intervention grounded in primary care, mFOCUS (multilevel FOllowup of Cancer Screening) to improve the follow-up of abnormal breast, cervical, colorectal and lung cancer screening results. The study is designed to evaluate the effectiveness of system, team and individual components of mFOCUS vs. standard care by conducting a 4-arm cluster randomized controlled trial (RCT) of 6,400 individuals, at 40 participating practice sites affiliated with three primary care networks, who are due for follow-up of an abnormal cancer screening test.